Payment Reform Policy and Cancer Disparities in Delivery of Radiotherapy

PROJECT ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-044.
Guideline-concordant radiotherapy is shifting from traditional long-course radiation to newer protocols that are
up to 80% shorter. The current fee-for-service (FFS) payment model serves as a barrier for shorter guideline-
concordant radiotherapy due to incentivizing longer, complex treatments without regard to quality of care. To
address this issue Medicare developed the Radiation Oncology Model (ROM). ROM changes payments to a
lump sum for radiation care delivered over a 90-day episode, shifting incentives to encourage efficient care
delivery over shorter periods of time. Key stakeholders have raised concerns regarding implementation of
ROM given uncertainty in how this payment policy will affect traditionally underserved patients, including
racially and ethnically minoritized, rural, and low socioeconomic status groups. This concern continues to serve
as a critical barrier to ROM implementation.
The purpose of this work is to provide a pre-policy evaluation addressing this key stakeholder concern. There
is little evidence to support that ROM implementation may harm traditionally underserved patients. We aim to
provide data-driven evidence to better inform ROM implementation.
The Specific Aims are to: 1. Determine disparities in receipt of guideline-concordant radiotherapy for
traditionally underserved populations. 2. Identify characteristics of practices that deliver more guideline-
concordant radiotherapy to traditionally underserved populations. We hypothesize that cancer patients from
traditionally underserved groups are less likely to receive guideline-concordant radiotherapy but that practices
serving a greater proportion of traditionally underserved patients will have increased delivery of guideline-
concordant radiotherapy for those groups. To accomplish these aims, we will utilize Medicare claims data to
analyze our cohort of patients aged 65 – 80 diagnosed with specified cancer types. We will utilize data from the
National Provider Identifier to analyze practices serving underserved populations. This work supports the goals
of the NCI through pre-policy evaluation, with findings that will aid ROM policy implementation to promote
guideline-concordant radiotherapy while reducing costs and minimizing risks of reducing access to care for
traditionally underserved patient populations.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH New payment systems for cancer radiotherapy including the Radiation Oncology Model may result in significant improvements in quality while reducing the cost of cancer care. Concerns remain that changing the payment system for radiotherapy might have unintended consequences that harm underserved patients. The objective of this pre-policy evaluation is to better understand the risks and potential benefits of implementation of the Radiation Oncology Model to traditionally underserved cancer patients.